Targetable epigenetic modifiers that promote neuroblastoma malignancy and plasticity

ABSTRACT
Neuroblastoma is an embryonal cancer of the sympathetic nervous system (SNS), caused by a developmental
block, that disproportionally causes 15% of pediatric cancer-related deaths. Patients with high-risk
neuroblastoma are treated with long-term intensive multi-modal therapies. Unfortunately, the 5-year overall
survival of high-risk patients is about 50% with limited options for the rest who have poor response or disease
relapse. Identifying the vulnerabilities of high-risk neuroblastoma and understanding the mechanism of therapy
resistance are critical for achieving more effective therapies. Recent transcriptomics studies and genome wide
CRISPR screening have identified core regulatory circuitry transcription factors (CRC TFs), which determine
SNS cellular or lineage identity during development, as neuroblastoma dependency genes. High-risk
neuroblastoma is a MYC-driven cancer with 50% of high-risk neuroblastoma having MYCN amplification while
another 10% has high c-MYC activity. Targeting CRC TFs or MYC TFs (N-MYC or c-MYC) is technically
challenging. Our preliminary data from the laboratories of Dr. Jun Yang and Dr. Kevin Freeman demonstrate that
targetable epigenetic modifiers including histone deacetylases (HDAC) and histone lysine demethylase 4 family
(KDM4) connect MYC to neuroblastoma specific CRC TFs. Our central hypothesis is that MYC oncogenes
are reliant on epigenetic factors to reenforce CRC TF regulated developmental blocks. Therefore, this
proposal will focus on understanding the interactions of MYC, CRC TFs and epigenetic modifiers in
neuroblastoma pathogenesis, and how to target their interactions for development of novel therapies.
Specifically, in Aim 1, we will determine the mechanism of how the bHLH transcription factor TCF4 promotes
MYC’s enforcement of pro-oncogenic CRCs, which we propose is through TCF4 recruitment of HDACs and that
understanding this mechanism will improve the application of HDAC therapy against high-risk neuroblastoma.
In Aim 2, we will determine the mechanism by which KDM4 inhibition disrupts CRCs and test the translational
feasibility of KDM4 blockade when combined with standard of care in high-risk neuroblastoma models. The
outcome of this study will result in a gain of mechanistic insights on how epigenetic modulators wire MYCs to
CRC TFs, and how to better target clinically relevant oncogenic drivers for NB clinical trials.

Public health relevance
Projective Narrative This project is to rigorously determine the mechanisms by which epigenetic modifiers wire MYC oncoproteins with core regulatory circuitry in high-risk neuroblastoma and cellular plasticity of neuroblastoma, and develop more effective therapies by targeting epigenetic modifiers in combination with standard of care.